Behavioral Phenoscreening: Remote Assessment of Child Mental Health (REACH)

SUMMARY
Externalizing problems, characterized by disruptive conduct, aggression, hyperactivity, attentional problems,
and the inability to adequately adapt to new situations, are leading contributors to health burden amongst
children and adolescents globally. A recent mental health surveillance among children in the United States
indicates one in 11 children have an attention deficit hyperactivity disorder (ADHD) diagnosis. Despite the
extraordinarily improved outcomes associated with early diagnosis and targeted intervention, externalizing
disorders such as ADHD and oppositional defiance disorder (ODD) are usually only diagnosed after symptoms
have clearly emerged and are causing significant impairments in daily functioning. This critical need for early-
life prediction of externalizing disorders can now be addressed, thanks to explosive advances in artificial
intelligence (AI) and widespread accessibility of remote technology. There is untapped opportunity to bring
simple, scalable and accessible solutions to families to improve detection and intervention of early emerging
externalizing disorders. Our proposal is responsive to the Individually Measured Phenotypes to Advance
Computational Translation in Mental Health Initiative, with the key objective of using computer vision and
machine learning based approaches to facilitate early identification of externalizing disorders. To achieve this,
we propose synergistic aims: Aim 1: Identify maternal-infant health and social determinants of health
predictors of externalizing disorders (ADHD, ODD, and conduct disorder (CD)) by employing a suite of
machine learning models to leverage an expansive nation-wide, representative cohort of >9M children with
birthing parent linkage (Epic Cosmos). Aim 2: Isolate a parsimonious set of infant and toddler behaviors,
derived via computer vision microcoding, by leveraging the expansive Healthy Brain and Child Development
(HBCD) study to integrate video, behavioral, cognitive, and survey data from 3,100 infants 9–15 months of age
to predict antecedents of psychopathology at 2 years of age; further, evaluate if specific patterns of infant
affect, arousal, and attention, as measured by microcoding, will significantly improve the prediction of
externalizing problems at age 2 compared to models using caregiver reports and EHR data. Aim 3: Develop
and validate a scalable, remote infant phenoscreening to characterize individual prediction models of
externalizing behaviors. We will combine and extend findings from SA1 and SA2 to develop a fully remote, low-
cost, brief parent-administered smartphone/web-based screening assessment of infant behavior in a new,
nationally representative cohort of 1,500 toddlers at 9–15 months of age. The innovation of this project is three-
fold: (i) identification of maternal and infant health predictors of externalizing disorders using large-scale, multi-
level data, (ii) addressing structural inequities in healthcare access and time to diagnosis through evaluation of
a highly scalable portal for multi-trait assessment at infant age 12 months, and (iii) use of AI to automatically
quantify infant behaviors predictive of future externalizing outcomes. The translational significance of this work
will be advancing low cost, accessible, scalable and accurate population screening in infancy; development of
more precise interventional targets; and alleviating socioeconomic disparities in diagnosis and intervention.

Public health relevance
NARRATIVE We will design and employ a remote phenoscreening assessment on a virtual platform that combines maternal self-report with computer vision and machine learning (ML) based analysis of infant behavior to predict externalizing problems at two years of age. Results of this study have potential for direct translation, as novel advances in remote phenoscreening and artificial intelligence make it possible to achieve widespread, real- time health surveillance in naturalistic settings at scale, a goal made even more important in the context of structural inequities in our health care systems.